Advancing Probe Technology for Ultrasensitive RNA Imaging via Hybridization Chain Reaction

Project Summary
Advancing Probe Technology for Ultrasensitive RNA Imaging via Hybridization Chain Reaction
Encoded in the genome of each organism, biological circuits direct development, maintain integrity in the face of
attacks, control responses to environmental stimuli, and sometimes malfunction to cause disease. RNA in situ
hybridization (RNA-ISH) methods provide drug developers, pathologists, and biologists with a critical window into
the spatial organization of this circuitry, enabling imaging of RNA expression in an anatomical context. While it is
desirable to perform multiplex experiments in which multiple targets are imaged quantitatively at high resolution
in a single specimen, using traditional RNA-ISH methods in whole-mount vertebrate embryos and thick tissue
sections, multiplexing is cumbersome, staining is non-quantitative, and spatial resolution is routinely compromised
by diffusion of reporter molecules. These multi-decade technological shortcomings have signiﬁcantly impeded
the study of gene regulatory networks in systems most relevant to human development and disease.
To overcome these challenges, in situ ampliﬁcation based on the mechanism of hybridization chain reaction
(HCR) draws on concepts from the new ﬁeld of dynamic nucleic acid nanotechnology to redeﬁne the state-of-the-
art for RNA ﬂuorescence in situ hybridization (RNA-FISH), achieving four breakthroughs in highly autoﬂuorescent
samples including whole-mount vertebrate embryos, thick brain slices, and FFPE tissue sections: 1) straight-
forward multiplexing with 1-step quantitative signal ampliﬁcation for up to 10 target mRNAs simultaneously; 2)
analog mRNA relative quantitation with subcellular resolution in an anatomical context; 3) digital mRNA abso-
lute quantitation with single-molecule resolution in an anatomical context; 4) automatic background suppression
throughout the protocol, dramatically enhancing performance and ease-of-use.
However, automatic background suppression is achieved using a dual-probe technology that does not apply
to short RNA targets (e.g., miRNAs) that are only long enough to stably bind a single probe. Moreover, for single-
molecule imaging of low-abundance mRNA targets, where each target molecule is resolved as a distinct dot,
variable probe hybridization yield due to competing secondary structure within the target leads to a distribution of
dot intensities that can overlap with autoﬂuorescence, leading to false-negatives or false-positives. The proposed
R&D will address these two critical technology gaps. To suppress background for imaging short RNA targets,
we will develop a new probe architecture that minimizes non-speciﬁc binding while preserving robust HCR am-
pliﬁcation. To achieve high-ﬁdelity single-molecule imaging across all classes of RNA targets, we will develop an
automated probe design pipeline that combines physics-based simulations with bioinformatics to generate probe
sequences with minimal off-target binding and high-yield hybridization to cognate RNA targets. These advances
will enable biologists, drug developers, and pathologists to perform ultrasensitive imaging of all classes of target
RNAs with anatomical context in the samples most relevant to human development and disease.

Public health relevance
Project Narrative Advancing Probe Technology for Ultrasensitive RNA Imaging via Hybridization Chain Reaction We propose to engineer and commercialize molecular technology that will enable simultaneous ultrasensitive imaging of multiple RNA molecules of different classes within sample types critical to drug development, clinical pathology, and biological research. The resulting products will enable the development of new therapies, the clinical diagnosis of disease, and the study of human biology and disease.